INCIDENCE OF THROMBOSIS SECONDARY TO CENTRAL VENOUS CATHETER IN NEONATES

The purpose of this study is to determine the incidence of thrombosis in infants who require prolonged central venous catheterization. Early identification of thrombosis and a better understanding of the contributing factors may help diminish the morbidity and mortality of this potentially life threatening complication.